Core 1: Facility Management, Maintenance and Operations Core

ABSTRACT- Facility Management, Maintenance and Operations Core (Core 1)
To serve the primary mission of the Duke RBL, it is imperative that the facility itself operates to the highest
operational standards. The overall goal of this Aim is to ensure that we can maintain reliable and uninterrupted
facility functionality. To achieve this goal, we focus on several critical elements: the facility must be safely and
effectively operated through a functional and seamless management process, inculcating a culture of safety
that permeates throughout the entire organization; the systems that are vital to the operation of the facility must
be well-maintained, and where appropriate the scheduled replacement of key systems must be planned prior
to any likely systems failure (i.e. before the end of the lifespan of the system or equipment). Finally, and
consistent with the aforementioned culture of safety, it is essential that facility meets or exceeds all of the
regulatory standards that are required for all of our systems and equipment. The goals of this Facility
Management, Maintenance and Operations Core (Core 1) are to 1) provide expert management and oversight
of the BSL-3 space; 2) ensure proper preventative maintenance of all critical systems; and 3) ensure
continuous compliance with all applicable regulatory standards. This Core is foundational to the safe and
effective operation of the Duke RBL core, and as with all programs dedicated to managing and minimizing risk,
embodies a culture of iterative improvement and the highest of operating standards.